Underscoring human oral host-pathogen interactions and modulation in an immunocompetent in vitro model of early dysbiosis

PROJECT SUMMARY
The human body hosts many distinct, interconnecting microbial populations that exert long-lasting,
systemic effects. Due to strong correlations of an imbalanced microbiome and disease prevalence (e.g.,
periodontitis, arthritis, and Alzheimer’s), studies of host-microbial interactions have increased in
importance. In particular, the oral microbiota is well known to have evolved mutualistically with the host,
is affected by the distinct architecture of the mouth, and is the primary modulator of oral diseases (e.g.,
gingivitis and periodontitis). This correlation strongly supports the need to understand the interactions
between the oral tissue niche, the oral microbiome, and the host tissue immune response; thus, offering
long-term opportunities to identify predictive disease biomarkers and to develop interventional
strategies that promote oral and overall health. We have recently reported the development and
validation of a 3D oral tissue model based on human primary cells that mimics the native tissue
organization and native oxygen gradient within the gingival pocket. These features enabled the long-
term culture and characterization of human microbiome with a physiologically relevant level of microbial
diversity under healthy and inflammatory conditions (i.e., gingivitis). Gingivitis, the highly prevalent
immunoinflammatory precursor to periodontitis, initially presents neutrophils, continuously recruited into
the gingival tissue to clear pathogenic microbes. The underlying immune-driven events play a major
role in the homeostatic balance between host and microbial communities, providing stability in healthy
conditions, while contributing to immune-inflammatory progression in periodontal disease states. Our
preliminary data further suggests important immunomodulatory roles for mucin glycans, lipoxins, and
resolvins in homeostatic maintenance and the prevention/progression of dysbiosis. However, these
observations, to date, have been generated using in vivo animal models, lacking mechanistic nuance
that would allow subsequent hypotheses regarding diagnostic/therapeutic roles. Leveraging our team’s
expertise in human in vitro modeling, microbiology, mucin biophysics, biogeography, and clinical
translation, we aim to leverage a 3D human oral tissue model to provide a mechanistic framework of
oral host-microbial interactions and modulation in early dysbiosis to support future therapeutic
interventions. Built on our published preliminary data, we propose to: (1) define clinically-relevant
profiles of early dysbiosis by monitoring host phenotypic changes as well as cytokine profiles in an
immunocompetent OTM compared to clinical gingival tissues; (2) correlate the modulatory role of mucin
glycans on the oral microbiome to the host tissue response; (3) deciphering the role of Lipoxin A4 and
resolvin E1 on the resolution of inflammatory host response in vitro.

Public health relevance
PROJECT NARRATIVE The dynamic and polymicrobial oral microbiome is the initiator of diseases such as periodontitis and dental cavities, globally, two of the most predominant microbially-induced disorders. A limited understanding of the homeostatic balance between host, microbiome, and immune system, together with a limited availability of current experimental tools, have hindered successful mimicry of ecosystem stability of healthy conditions or the progression of immune-inflammatory destructive tissue states, as in the case of oral and periodontal diseases. In this proposal, we aim to leverage a 3D human oral tissue model to provide a mechanistic framework of oral host-microbial interactions and modulation in early dysbiosis to support future therapeutic interventions.